BUSINESS ANALYST SERVICES TO SUPPORT THE FEDERALLY FUNDED RESEARCH AND DEVELOPMENT CENTER (FFRDC) CONTRACTOR'S BUSINESS SYSTEMS.

BUSINESS ANALYST SERVICES TO ACHIEVE A BETTER UNDERSTANDING OF THE BUSINESS PROCESSES OF THE FEDERALLY FUNDED RESEARCH AND DEVELOPMENT CENTER (FFRDC) CONTRACTOR'S BUSINESS SYSTEMS.